Synthetic RNA Switch-Based Temporal and Dose Control of in Vivo Gene Therapies

PROJECT SUMMARY
One-time in vivo gene therapies, based on adeno-associated viral (AAV) vector delivery of genes encoding
therapeutic proteins, noncoding RNAs, or genome/epigenome editors, may provide long-lasting (years of, or
even lifelong) treatments or cures for many rare and common diseases. However, we cannot currently tune or
inactivate transgene expression to reflect disease progression or the emergence of adverse events or
contraindications over time, limiting the utility of AAV gene therapies. The constrained packaging capacity of
AAV vectors (~4.7 kb) has thwarted development of genetic switches that can regulate transgene expression
timing or levels—the solution to these limitations. To date, just a few AAV-compatible switches function in
animals. Typically, these switches are activated or repressed by ligands with undesirable side effect, including
rapamycin, a potent immune suppressant; tetracycline, an antibiotic not suitable for chronic use; and
branaplam, a compound that causes peripheral neurotoxicity. We previously engineered an efficient synthetic
RNA ON switch based on our novel self-cleaving ribozyme T3H38, which is regulated by a complementary
morpholino oligonucleotide. At 63 bp long, the tiny T3H38 ribozyme can be inserted into the 3′ UTR of a
transgene. Its regulator, a 25 nt morpholino oligo is part of a class of chemically modified RNA drugs that have
proven safe for chronic use in humans. The T3H38 ribozyme showed a ~200-fold regulation in AAV transgene
expression in mice upon administration of the complementary morpholino oligo to the animals. Optimizing the
T3H38 ribozyme switch towards a leak-free system with no detectable baseline transgene expression in the
absence of the morpholino oligo could transform AAV-based gene therapy. For example, it can enable safe
use of AAV to express a variety of transgenes with narrow therapeutic windows (e.g., cytokines, hormones,
genome editors), where an overdose or prolonged exposure can cause severe adverse events, or to
conditionally express therapeutics with major contraindications (e.g., cytokines), specific disease conditions
where a drug should not be used or should be discontinued. In preliminary studies, we have developed an
enhanced RNA ON switch (regulatory range: up to 35,000-fold in mice) based on the T3H38 ribozyme. Here,
we will (i) optimize the enhanced RNA switch to engineer an ultra-efficient switch with negligible leakiness; (ii)
use the optimized switch for precise dose control of an AAV expressing erythropoietin—a paradigmatic biologic
with a short half-life, a narrow therapeutic window, and major contraindications—for the treatment of chronic
Epo-deficient anemia in a mouse model; and (iii) further optimize the switch system in mouse airways for
temporal control of an AAV expressing a broadly anti-coronavirus immunoadhesin—a prototype of a broadly
effective prophylaxis for immunocompromised individuals against a panel of coronaviruses of pandemic
potential. The completion of this project will provide a broadly useful and potentially transformative regulatable
gene therapy technology and proofs of concept showcasing the utility of this technology.

Public health relevance
PROJECT NARRATIVE Genetic switches that allow precise temporal and dose control of transgene expression in vivo can improve safety and efficacy and expand the use of adeno-associated viral (AAV) vector-delivered one-time in vivo gene therapy, which has proven effective in providing long-lasting (years of, or even lifelong) treatments for several rare genetic diseases. Synthetic RNA switches, which are cis-acting RNA devices that can control gene expression independent of any protein factors and have AAV-friendly tiny size, have key strengths over other regulation systems and are a perfect fit for precision control of AAV gene therapies. Here, we will develop an ultra-efficient RNA ON switch and use two proof-of-concept studies in mice to test the feasibility of developing RNA switch-regulated ‘bio-factory’ gene therapy, to safely express short-lived biologics with narrow therapeutic windows or biologics that require regulation of their expression timing, for the treatment of two common diseases.